Exposome-on-a-chip: eliminating the elusiveness of the flavonoid hesperidin effect on bone and BMP function

Abstract
Bone morphogenetic protein as a bone regeneration biologic has experienced steady decline in use given its side effects.
Our published work has shown, for the first time, that a natural compound, dietary hesperidin (HE), can control BMP side
effects likely via multiple mechanisms. These include control of inflammation, osteogenesis and osteocyte function in
regenerated and native mandible bone. Due to the complexities of the multifactorial effect of phytochemicals such as HE, a
multi-cellular system mimicking the bone environment would be an ideal ex-vivo setting for undertaking mechanistic
studies to understand its role on BMP function and craniofacial bone. Such system could be targeted to simulate the
mechanics of the bone environment given specific shear stresses. Based on preliminary data, it is our hypothesis that HE
limits inflammation induced by exogenous BMP2 via TLR receptors, and that it can promote new high-quality bone
formation via its modulation of osteoblast-osteocyte interaction, promoting BMP signaling, favoring fast matrix remodeling
and Ca2+ deposition. Further, this grant proposes the utilization of an innovative 3D co-culture platform which will facilitate
the understanding of the effect of the bone exposome containing HE +/- BMP on bone cells and allow data collection in a
bone network set to mimic the microenvironment. This proposal is in response to the NIH RFA DE-025-002 which will
support the validation of novel dental, oral and craniofacial (DOC) organ-on-a-chip (OoC). The proposal offers high reward
since, if successful, will provide further understanding of BMP2 function in bone regeneration, a novel approach on
modulation of BMP2 via phytochemicals and ultimately, provide validation of a new 3D bone culture system mimicking
the bone cell interactions under mandible-like mechanics (frequent shear stresses) (the OoC). The results can be compared
to our previous pre-clinical studies and ultimately the proposed bone exposome-on-a-chip may offer validation, equivalence
and perhaps outperform animal testing.

Public health relevance
Narrative A significant number of BMP-induced bone grafting surgeries face challenges due to inadequate bone formation and adverse events like excessive site inflammation. Our published preliminary data reveal that the natural compound hesperidin enhances osteogenesis both in vitro and in vivo in a pre-clinical mandible bone defect model, significantly improving the function of BMP2 and controlling inflammation. This study will employ organ-on-a-chip technology in a mechanically stimulated bone environment to gain mechanistic insights into hesperidin/BMP therapy and the introduction of this platform, termed the bone exposome-on-a-chip, holds great potential for future drug testing for craniofacial and skeletal bone applications.